Genomic, Spatial Transcriptomic, Epigenomic and Single Cell Shared Resource

PROJECT SUMMARY/ABSTRACT: GENOMIC, SPATIAL, TRANSCRIPTOMIC, EPIGENOMIC AND SINGLE CELL
SHARED RESOURCE (GSTESC)
The Genomic, Spatial, Transcriptomic, Epigenomic, and Single Cell (GSTESC) Shared Resource (SR) of the Dan L Duncan Comprehensive Cancer Center (DLDCCC) fulfills the academic needs of Cancer Center investigators by providing cutting-edge technologies and supports research flexibility by assisting with development of innovative new applications. The GSTESC SR is a dynamic facility with a mission of keeping pace with emerging technologies and instrumentation and the changing needs of the Cancer Center. Over the last four years, $2.5 million has been invested from grants and Baylor College of Medicine for new high-end instruments. DLDCCC investigators have made significant advancements in cancer research by utilizing GSTESC state-of-the-art next generation (NextGen) sequencing, spatial and single cell technologies for their genomic, transcriptomic, and epigenetic studies. As a rapidly evolving field, the barriers and costs of NextGen sequencing and single cell approaches can be high and the continuing change in instrumentation needs for these technologies are far more than most individual investigators can support. In addition, spatial profiling represents an emerging technology with both sequencing and imaging-based chemistries that require cross-disciplinary expertise. Under the DLDCCC umbrella, the GSTESC collaborates with other SRs in order to streamline spatial and other multi-omics studies. A SR facility such as GSTESC, closes the technology gap to enable individual and collaborative DLDCCC research groups to successfully utilize current and emerging NextGen sequencing technologies in their research with cost efficiency, accuracy, and convenience that would otherwise not be possible. The GSTESC is also supported by a CPRIT (Cancer Prevention and Research Institute of Texas) Core Facility Support Award (CFSA) for developing and supporting epigenomics applications for a broad range of researchers including assays for profiling histone modifications, chromatin accessibility, DNA methylation and RNA modifications. The GSTESC also supports other CPRIT CFSA projects including multi-omic profiling studies of PDX models and human clinical samples. Finally, the GSTESC is heavily involved in educational outreach by co-directing Molecular Methods and Advanced Technology Skills courses in the BCM Master’s in Biomedical Science Program, leading classroom-based and lab-based workshops for graduate students sponsored by the Department of Education, Innovation & Technology and the Huffington Foundation. Leaders of GSTESC also organize and host an annual single cell omics symposium and single cell data analysis workshops, participate in the NIH R25 BCM Biotechnology Research Incubator for Teachers (BCM-BRITE), the Summer Undergraduate Research Training (SMART) program and the annual conference of the Southeastern Association of Shared Resources (SEASR) that provides a regional forum for core directors and staff.